Expanded Role of Primary Care Pharmacists in the Management of Heart Failure

Justification. Heart failure (HF) is a common condition in the VA, with high morbidity and mortality.
Accordingly, HF hospitalization and mortality are a focus of VA Safety Analytics for Improvement and Learning
(SAIL). Furthermore, HF medical treatment is complex as there are now four classes of medications known to
independently prolong survival and are recommended to be used together (five for African Americans).
Several medications require titration to recommended doses while monitoring for uncommon but dangerous
side effects. Given the complexity of treatment and the insufficient number of cardiologists to manage this
large patient population, standardized medication initiation and titration of medications by non-physicians has
been tested as an adjunct to current primary care practice of patient aligned care teams (PACT). Pharmacist
medication initiation and titration of medications has been found to improve recommended care in multiple
randomized trials. However, few VA sites have implemented medication initiation and titration of medications
for HF by PACT pharmacists. Hypothesis: Pharmacy medication initiation and titration of HF medications can
be implemented successfully at two sites in VA Palo Alto HCS and will increase recommended use of three
medication classes for Veterans with HF. Gaps Addressed (Knowledge and Practices). A National HF
Dashboard is available to track guideline recommended therapy and shows many patients are not receiving
optimal HF car e. Innovation. The use of PACT pharmacists to provide protocolized care for HF will free up
primary care providers from this work allowing them to increase access to primary care. Given that patients are
often referred to VA Cardiology for this task, pharmacist management can also improve access to VA
Cardiology. Specific Aims 1) Implement pharmacist led protocolized care in PACTs for the initiation and
titration of HF medications at two types of primary care sites. 2) Determine facilitators, barriers, fidelity and cost
of implementation. 3) Demonstrate an impact on recommended HF care and increased access to VA Primary
Care and VA Cardiology as a result of PACT pharmacist management. Project Methods We have partnered
with pharmacy and PACT leadership at VA Palo Alto HCS in their use of PACT pharmacist HF medication
management at one CBOC (Monterey, CA). In this project we will spread this practice to two types of sites: VA
Palo Alto Medical Center based Primary Care Clinic (large) and the VA San Jose CBOC, CA (small).
Implementation Strategies As part of the proposed project we (partnership of the VISN CMO Dr. Godbout
and the QUERI Team) will 1) organize local champions, 2) facilitate spread to the two sites and 3) provide
audit and feedback to PACT pharmacy and primary care leadership. We will bring together local champions
(VA Pharmacy, VA Primary Care and VA Cardiology leadership) who will be shown results over time and will
provide advice on how to modify the implementation for their site. To facilitate implementation, we will develop
and provide an operation manual and toolkit that includes pharmacy medication management protocols.
Evaluation Our evaluation will examine implementation (e.g. fidelity, barriers, facilitators, cost, provider
satisfaction, employee engagement) and outcomes (fraction of patients meeting guideline recommended care,
access). Description of primary outcomes/endpoints. The implementation outcomes will include the
number of HF patients managed by pharmacists per month per PACT team, and number of medication
changes made by PACT pharmacists per month per PACT team. Pharmacist and primary provider satisfaction
and perceived burden with the expanded pharmacist role will be determined. Cost of implementation will be
determined and compared with benefits (increased access, increased quality of care metrics) to provide both a
business case analysis and return on investment. The care outcomes will be use of five VA recommended HF
medication classes from the National VA HF Dashboard, access/wait times for PACT and VA Cardiology
appointments, admission, readmission, mortality, emergency department visits and adverse drug reactions.

Public health relevance
Our QUERI-VISN PII Start-Up project will implement a new evidence-based practice: using PACT pharmacists to help manage heart failure (HF) care. This project will both improve guideline recommended care and increase access to primary care by freeing up primary care providers. By increasing medication use we expect both HF hospitalization and Veteran survival to improve. Our implementation strategies include organization and support of local champions, facilitation of the pharmacist work and audit and feedback. This work impacts several Strategic Analytics for Improvement and Learning (SAIL) metrics and publically reported outcomes on Hospital Compare. Our proposal will build upon existing strong relationships between the project leads (who have a long history of conducting successful QUERI projects), and our operations partners including VISN 21 Pharmacy Benefits Management. We have pilot tested this practice at one site and this start-up program will test it at two additional sites. Following this work, we hope to expand the implementation to multiple VISNs.